ACTG 333--HARD CAPSULE AND SOFT CAPSULE SAQUINAVIR VS INDINAVIR

The activiral effect of switching from saquinavir to the new formulation of saquinavir vs. indinavir after more than one year of saquinovir use.